Modeling the development, age structure and maintenance of T cell populations

? DESCRIPTION (provided by applicant): Maintaining diverse repertoires of naive and memory T cells provides vital protection against both novel and previously-encountered pathogens, and loss or dysregulation of these populations has catastrophic implications for health. However, while we have qualitative knowledge of the signals that inﬂuence T cell division and survival, we lack an integrated understanding of the mechanisms that regulate the sizes and T cell receptor (TCR) diversities of T cell compartments. Solving this `immuno-ecology` problem, and developing validated, quantitative models of the dynamics of our T cell repertoires, will give a basis for therapies in many areas; reversing the collapse in TCR diversity with age, which may impair responses to vaccines and infections; aiding T cell reconstitution following bone marrow transplants; treating dis- orders that disrupt homeostasis, such as leukemia's and HIV infection; and designing vaccines that boost immunity without impairing T cell memory to other pathogens. The goals of this project are (i) to fully characterize the rules governing the incorporation of new cells from the thymus into our naive T cell pools, identify age-related heterogeneity in naive T cell kinetics, and establish the impact of such heterogeneity on cell's functional responsiveness; and (ii) to extend this focus to memory T cell subsets to identify the rules governing birth and death within each. To achieve these goals we will use a combination of mathematical modeling and dedicated experiments in mice, connecting our results to mechanisms of T cell homeostasis in humans wherever possible. Achieving the aims of this proposal will be a long stride towards our long-term goal of an integrated, validated and quantitative model of human T cell homeostasis.

Public health relevance
PUBLIC HEALTH RELEVANCE: T lymphocytes are circulating white blood cells that are essential for immunity to infections. In this project we aim to understand how these cells are maintained. Such an understanding will help us develop better treatments for restoring T lymphocytes that are lost following, for example, radiation therapy or HIV infection.